SHARING IN THE DISCOVERY STEM CELL OUTREACH LEARNING LAB

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Objective: To inform and educate the public about stem cell and regenerative medicine research at the UW-Madison. To engage teachers and students and provide resources and ideas for teaching and learning about stem cell and regenerative medicine. This is a continuing collaborative effort among the UW-Madison Stem Cell and Regenerative Medicine Center, Biotech Center, Primate Center and their outreach partners. The project leader is Jordana Lenon, B.S., and she employs a student hourly lab manager. In 2009-2010, we continued to improve and streamline our stem cell learning lab experiences to serve a variety of audiences. As a result, we reached more than 2,000 people directly with our outreach efforts during this reporting year. Before or after the lab experience, many groups visited the Primate Center and learned about its important role in UW-Madison stem cell history, as well as current research and animal care. Outreach visits to the Primate Center have quadrupled since past years due to the expanded outreach opportunities afforded by this grant. Through this project, we have also scheduled UW-Madison stem cell and regenerative medicine speakers to present to numerous audiences about this broad scientific field. Our speakers have included principal investigators, post-doctoral trainees and both graduate and undergraduate students. This project relies on the time and resources of the WNPRC Public Information Officer, who is also a university relations specialist for the Stem Cell and Regenerative Medicine Center.